Genomic correlates of outcome in pleuropulmonary blastoma

Project Summary/Abstract
Pleuropulmonary blastoma (PPB) is the most common pediatric lung cancer in children and one of the
sentinel manifestations of DICER1-related tumor predisposition. While some patients with PPB may be treated
with surgery alone, children with advanced PPB require an intense combination of surgery, chemotherapy and
often radiation. Unresectable or recurrent disease is associated with a poor prognosis. Currently, there are no
molecular factors sufficiently predictive to allow risk stratification in advanced PPB and no ways to rationally
target oncogenic DICER1 variants. The DICER1 enzyme normally produces mature microRNAs by cleaving the
two arms of a pre-microRNA hairpin, and PPBs typically exhibit a loss-of-function variant on one DICER1 allele
and a missense variant on the second allele, predominantly affecting one of five specific “hotspot” positions.
These hotspot variants in DICER1 impair cleavage of microRNAs derived from the 5p arms of pre-microRNA
hairpins (“5p microRNAs”) but allow cleavage of 3p microRNAs. Although these hotspots have previously been
thought of as interchangeable, our analysis suggests that hotspot variants differ in clinical prognosis, ability to
engraft as patient-derived xenografts (PDXs), and expression of 5p microRNAs. More severe impairment of 5p
microRNAs leads to higher levels of genes targeted by 5p microRNAs, including MYC. Thus, here we will
examine the clinical and functional impact of DICER1 variants in PPB with the following specific aims: AIM 1. To
validate the prognostic significance of DICER1 variants in PPB, we will correlate hotspot with clinical outcome
and PDX engraftment in a larger set of tumors. AIM 2. To test whether DICER1 variants have different effects
on 5p microRNA production, we will analyze more tumors, and we will model hotspot variants in cell-free assays
and in cell lines. AIM 3. To evaluate therapeutic strategies for targeting MYC in PPB, we will test silencing and
inhibition of MYC cofactors in PPB cell lines and xenografts. The overall goal of our research program is to
improve outcomes for patients with PPB and other DICER1-related cancers. If successful, this project could
advance molecular risk stratification in PPB and identify novel therapeutic approaches to target these tumors.

Public health relevance
Project Narrative Pleuropulmonary blastoma is the most common lung cancer in children and the deadliest cancer associated with alterations in a gene called DICER1. This project studies how different DICER1 alterations produce distinct biological and clinical effects, and it investigates a new treatment strategy that could overcome these differences.